Addressing the Complex Driving Continuum: Needs of an Aging Population

Project Summary/Abstract
The proposed three-year conference series entitled “Addressing the Complex Driving Continuum:
Needs of an Aging Population” (ACDC: NAP), centered around aging, mobility, and transportation safety, aims
to bring together leading experts from various fields such as geriatrics, neurology, public health, and
transportation and mobility. This series is essential to address the needs of an aging population, particularly in
integrating new technologies like Advanced Driver Assistance Systems and artificial intelligence to enhance
mobility and driving safety for older adults. The conference series will provide a space for clinicians,
policymakers, researchers, community organizations, and industry partners to assess the current state of
research, investigate current clinical practices for evaluating crash risk, and examine national public
policy/advocacy initiatives surrounding unsafe driving and resources for alternative transportation options with
a special emphasis on involving underrepresented communities, rural populations, and low-income older
adults. The conference will provide a platform for interdisciplinary collaboration, fostering new research and
generating actionable strategies to bridge the current gaps in research and practice.
The first conference to initiate this series will be held locally at Washington University School of
Medicine in St. Louis in the fall of 2025, followed by national conferences in 2026 and 2027 in partnership with
the Gerontological Society of America (GSA). The aims of this conference series will be to examine research
that identifies age-related medical risk factors (e.g., visual impairments, Alzheimer’s disease, Parkinson’s,
stroke) that increase crash risks and investigate evidence on assessment tools of driving-related abilities. It will
also focus on interventions to enhance physical and cognitive skills and technologies to support the unique
needs of older drivers and generate consensus on the decision-making process around driving cessation, its
impact on older adults’ health and well-being, and alternative transportation options to sustain their
independence. The conference will receive guidance and support from aging, transportation, and ADRD
experts to ensure a comprehensive and impactful discussion. Dissemination strategies include peer-reviewed
publications, webinars, podcasts, and community outreach efforts. By convening national experts from aging,
allied health, transportation and mobility, neurology, geriatrics, gerontology, and public health fields, the
conference is expected to foster new collaborations and generate actionable strategies to address current
gaps.

Public health relevance
Project Narrative The number of drivers aged 65+ in the United States is expected to rise from 17% in 2024 to over 25% by 2050; however, older adults face a higher crash risk than middle-aged drivers, with motor vehicle crashes being a leading cause of injury and death. Despite this trend, there have yet to be any recent national conferences to discuss strategies for optimizing late-life mobility. The three-year conference, “Addressing the Complex Driving Continuum: Needs of an Aging Population” (ACDC: NAP), will invite clinicians, researchers, and policy-makers to discuss factors increasing crash risk, tools for assessing driving-related abilities, support older drivers' needs, and build consensus health, and alternative transportation to maintain independence.